Analyses of the Distributed Representation of Associative-Learning in an Identified Circuit Using a Combination of Single-Cell Electrophysiology and Multicellular Voltage-Sensitive Dye Recordings

PROJECT SUMMARY/ABSTRACT
Although significant advances have been made in elucidating the cellular, biophysical and molecular
mechanisms of learning and memory, much less is known about the ways in which mnemonic processes are
embedded in neuronal networks. The overall goal of this proposal is to provide insights into the design principles
that govern the implementation of memories within the complex environment of a neural circuit. Studies will focus
on an established in vitro analogue of operant conditioning (QC) in a relatively complex circuit, which is amenable
to population-wide, cellular, and biophysical analyses. A combination of intra- and extracellular
electrophysiological techniques, voltage-sensitive dye (VSD) imaging, dimensionality reduction analysis, and
computational modeling will identify and characterize loci of non-synaptic and synaptic plasticity. In addition, the
project will examine the extent to which plasticity loci are shared between short- and long-term memory. Aim 1
will use intracellular recording techniques to examine loci of QC-induced plasticity. Previous correlates of OC in
this model system were restricted to increases in intrinsic excitability or electrical synapses of key neurons in the
circuit. Our recent results indicate QC also decreases the strength of an inhibitory synapse and the excitability
of a key neuron in the circuit. Aim 1 will examine other prime candidates of QC-induced synaptic and non-synaptic
plasticity, which have an established role in mediating the behavior. In addition, we will use intracellular
techniques to examine regions of the circuit that our recent VSD recordings have shown to exhibit QC-induced
changes in activity. Computational modeling will assess the ways in which loci work unilaterally or synergistically
to mediate the OC phenotype. Aim 2 will use a combination of intracellular recordings, VSD imaging, and
dimensionality reduction approaches to expand the search for additional sites of QC-induced plasticity and
search for low-dimensional 'signatures' of OC. The combined results from Aims 1 and 2 will provide for an
assessment of the scope of plasticity mechanisms associated with OC that is unprecedented in any system. A
further important question will be addressed by Aim 3, which will determine the extent to which sites for short-term
memory persist during long-term memory and, conversely, which sites of plasticity may be unique to long-term
memory. The present proposal will help develop a comprehensive understanding of the ways in which
memories are encoded in a relatively complex circuit, elucidate design principles of memory encoding, and
provide guidance for similar analyses in more complex systems.

Public health relevance
PROJECT NARRATIVE A central tenet of neuroscience is that memory storage involves changes in the functional properties of neuronal networks and that memory deficits are associated with disruptions in network function. Studies outlined in this proposal will use a relatively complex, yet tractable, neuronal network to examine the distributed representation of the memory for operant conditioning, a ubiquitous form of associative learning in which a subject learns from the consequences of its behavior. A deeper understanding of the design principles that govern the implementation of mnemonic mechanisms in neuronal networks may help guide the development of better treatments for neural dysfunction, and thereby improve human brain health.